Community Outreach and Adoption

PROJECT SUMMARY (Project 2: Community Outreach and Adoption)
The Human Pangenome Reference Consortium Coordination Center will extend its outreach efforts to strengthen
the HPRC’s collaborations with scientific, clinical, and other stakeholder communities, and to foster the
development of a new ecosystem of analysis tools that involves broad community engagement via training and
education. We will do this by synergizing with adopter programs to facilitate collaborative science. We will form
a Cross-Consortia Working Group which will comprise members of sister consortia and meet regularly to promote
adoption of the pangenome by enhancing communications across the programs and by coordinating
collaborative projects, analysis efforts, and development of tools for using the new reference. We will coordinate
and host cross-consortia meetings and jamborees focused on incorporating the pangenome reference into
pipelines of various consortia labs and clinical labs to see if molecular diagnoses change, new variation is found,
haplotypes are better defined, and benchmarks are better defined. We will also develop a framework for
international partnerships, collaborations, and coordinating activities that respect non-western modes of data
ownership and ensures bi-directional knowledge exchange. We will identify, recruit, and facilitate future
international partnerships and the democratization of the pangenome reference by developing and supporting
the Human Pangenome Project, and creating a framework and infrastructure that will extend well beyond the
next phase of the HPRC.